Mayo Alzheimer's Disease Research Center

PROJECT SUMMARY/ABSTRACT - OVERALL
The overall goal of Mayo Clinic Alzheimer's Disease Research Center (ADRC) is to provide a
structured environment that supports innovative research and enables translation aimed at accelerating
the development of effective treatment and prevention for AD patients at all stages of the disease. Our
comprehensive ADRC is located in Rochester, Minnesota (MCR), and Jacksonville, Florida (MCF), and
shares its operations in all of the Cores between the two geographic sites. The sites are linked
electronically yielding a seamless operation. The ADRC will be comprised of seven cores:
Administrative Core, Clinical Core, Neuropathology Core, Data Management and Statistical Core,
Outreach, Recruitment and Engagement Core, Neuroimaging Core and a new Biomarker Core. In
addition, the Center will have a Research Education Component. The Mayo ADRC focuses on both
Alzheimer's disease (AD) and Alzheimer's disease related dementias (ADRD) such as frontotemporal
lobar degeneration and Lewy body disorders. As such, the theme of the ADRC is Similarities and
Differences among Neurodegenerative Diseases. This focus will expand on previous accomplishments
of the ADRC across the neurodegenerative disease spectra. The acquisition and development of new
biomarkers for the neurodegenerative diseases will be a major focus of the Center, and the recruitment
of research participants in all three disorders will enhance randomized controlled trial studies. A major
emphasis of the new grant period will be the development of the Research Education Component with
activities for trainees at all levels. Mayo Clinic has extensive educational resources for both local and
national impact and these resources will be leveraged to attract and retain early stage investigators and
those who are new to dementia research with an emphasis on diversity. The Mayo ADRC will interact
with other ADRCs on various collaborative efforts and will continue to be a major contributor to the field.

Public health relevance
NARRATIVE – OVERALL The Mayo Clinic Alzheimer's Disease Research Center will focus on the theme of the “Similarities and Differences Among Neurodegenerative Diseases.” We will study Alzheimer's Disease, frontotemporal lobar degeneration and Lewy body disorders with respect to clinical features, neuroimaging and fluid biomarkers as well as pathological consequences. The Center will recruit participants with these diagnoses, train new investigators and emphasize diversity in all aspects of its operation. Ultimately, by studying these disorders together, we will hopefully understand the biological underpinnings leading to successful therapies.